Environmental Career Worker Training Program

ECWT Program Summary/Abstract
The overall goal of WRUC’s Environmental Career Worker Training Program (ECWTP) is to
train individuals for jobs in the construction, environmental remediation, energy efficiency, and
hazardous waste fields with a focus on recruiting from underserved communities
disproportionately affected by environmental exposures. WRUC accomplishes this goal through
comprehensive training and wrap-around services that reinforce worker health and safety and
job readiness to support both environmental and economic sustainability in disenfranchised
communities. In the next five years, WRUC plans to recruit and train 190 students per year from
underserved and marginalized communities in the cities of Los Angeles and Portland, and in
remote tribal villages in Alaska. Our consortium provides support to trainees through a program
of consistent mentoring, from initial recruitment to job placement and retention. WRUC has
strategic partnerships in each location to sustain our program’s ability to conduct outreach and
recruitment, training, job placement, and tracking activities. The program capitalizes on
changing labor market demands and on green job career pipelines in each target location.